Less Lumping, Smarter Splitting: Genomics and Metabolomics of Systemic Steroid Response in Bronchopulmonary Dysplasia

Project Summary/Abstract 2.5 million infants are born at less than 32 weeks gestation worldwide every year, with approximately 75,000 of them born in the US. Many of these preterm infants develop a severe form of lung disease called Bronchopulmonary Dysplasia (BPD), which manifests as poor lung function requiring prolonged mechanical ventilation and oxygen therapy, and predisposing to poorer neurodevelopmental outcomes. In addition, these children exhibit increased fragility to lung infections and often require hospital readmissions in the first year of life. Severe Bronchopulmonary Dysplasia is one of the most important pediatric pulmonary disorder in the United States, increasing in incidence as increasing numbers of extremely preterm infants survive to leave the ICU. One commonly used drug therapy for BPD is systemic steroids, including the corticosteroids dexamethasone and hydrocortisone, which produces variable and unpredictable short term pulmonary benefit, but are associated with neurodevelopmental impairment and other important side effects such as growth stunting, hypertension and decreased bone mineralization. Given the variable clinical efficacy and high risk for adverse effects, it is important to identify a group of infants with BPD who will benefit the most from steroid therapy, making the risk of adverse events more acceptable. There are functionally important genetic variants known to impact steroid metabolism and response in similar patient populations, so we know that variability in steroid response likely has, in part, genetic underpinnings. In a prospectively recruited multi-site cohort (N=150), we will assess genomic and metabolomic markers which correlate with steroid response in BPD. We will capitalize on prior published knowledge and pilot data, as well as take an agnostic approach, to identify genomic biomarkers of steroid response among preterm infants treated with systemic dexamethasone or hydrocortisone for BPD. We will also compare the urine and plasma pharmacometabolome between steroid responders and non-responders to look for pre-treatment or early treatment markers of drug efficacy. The overall goal of the research program is to elucidate genomic and metabolomics biomarkers of clinical response, as a mechanism to identify a group of infants with the most favorable risk to benefit ratio, moving the field of BPD treatment towards precision medicine. This project fits well with the mission of the NICHD Obstetric and Pediatric Pharmacology branch, because it addresses a severe pediatric disease with highly variable and unpredictable drug response (efficacy and toxicity). The systematic application of modern pharmacology research tools will allow the identification of certain preterm infants, either a priori or early in the treatment course, who will have clinical benefit >>toxicity risk, allowing for personalized therapeutics in this group of infants.

Public health relevance
Project Narrative Bronchopulmonary Dysplasia (BPD) is a severe lung disease resulting from preterm birth, which currently has no FDA approved drug therapies. Systemic steroids are commonly used, but have highly variable and unpredictable efficacy, exposing many infants to the risk of steroids without significant benefit. The proposed pharmacogenomic and pharmacometabolimic research project will help develop tools to identify infants with the highest likelihood of drug response, moving BPD treatment towards precision therapeutics, and improving care for this patient population.